Clinical, Neuroanatomic, and Pathologic Signatures of FTLD-tau in Dementia Phenotypes - Diversity Supplement (Antwan Howard)

Abstract of the Funded Project (R01 AG062566).
Frontotemporal lobar degeneration (FTLD) is a neurodegenerative disease found at autopsy that underlies a
variety of clinical dementia syndromes, and is the second most common cause of dementia under age 65 [1].
Patients with FTLD-related dementias are underserved in part because the complex relationship between
dementias and underlying pathology is not well understood. Much of the complexity lies in the fact that the same
pathology can cause different dementia syndromes and, conversely, that a single dementia syndrome can be
caused by multiple pathologies. The goal of this proposal is to disentangle the complex relationship between
dementia syndromes, anatomic atrophy, cell death, and a specific form of FTLD, known as FTLD-tau. In doing
so, this work will help identify the putative substrates of neurodegeneration in FTLD-tau.
This study focuses on a robust cohort of postmortem human specimens that show the most common forms of
FTLD-tau: Pick’s disease and the frontotemporal lobar tauopathies of the corticobasal and progressive
supranuclear palsy types (CBD-PSP). These tauopathies can underlie primary progressive aphasia (PPA), a
clinical dementia syndrome characterized by progressive language impairment, and behavioral variant
frontotemporal dementia (bvFTD), a clinical dementia syndrome characterized by progressive changes in
comportment. Aim 1 will determine the specific targets and cellular features of a single tauopathy (Pick’s
disease) in cases diagnosed antemortem with different dementia syndromes: the semantic and agrammatic
variants of PPA (PPA-S and PPA-G, respectively) and bvFTD. These dementia syndromes are each associated
with distinct patterns of atrophy and clinical profiles, providing an ideal model to explore the selective
vulnerabilities of anatomic regions responsible for cognition or behavior. Aim 2 will study the converse
relationship by investigating multiple pathologies (Pick’s disease and CBD-PSP) in cases diagnosed antemortem
with a single dementia syndrome (PPA-G or bvFTD). Histological and unbiased stereological methods will be
used to determine relationships between FTLD-tau pathology, not only to detailed clinical profiles and
quantitative MRI atrophy patterns, but also to neuronal, glial, and synaptic abnormalities. A central hypothesis
of this work is that regional distributions of FTLD-tau—and related cellular features—will show concordance with
anatomic patterns of atrophy and distinct clinical profiles.
This is one of the first works of its kind that aims to establish clinical, anatomic, and pathologic concordance of
high specificity between clinical dementia syndromes and the tauopathies that cause them. PPA and bvFTD,
specifically, offer exciting opportunities for exploring the organization and pathologic targets of anatomic
networks in neurodegenerative diseases. Outcomes of this multidisciplinary study will clarify the pathologic
underpinnings of clinical heterogeneity in dementias, sharpen our understanding of the principles of selective
vulnerability, and are highly relevant for the development of tauopathy-specific diagnostic tools and treatments.

Public health relevance
PUBLIC HEALTH RELEVANCE. Inclusions of the transactive DNA binding protein 43 (TDP-43) are present in an overwhelming majority of elderly individuals with Alzheimer's disease (AD). These co-occurring diseases lead to dementia, functional decline, and brain changes in the elderly—a population that is steadily rising worldwide. The current study will address this major public health challenge by investigating the underling neurobiological signatures and mechanistic contributions of TDP-43 in AD, with the long-term goal of contributing to the development of targeted interventions for dementia.